Mitigating the Spread of Misinformation and Disinformation about COVID-19 Prevention and Treatment Initiatives among Hispanics

Considerable evidence exists on the role misinformation and disinformation has played on COVID-19 vaccination
hesitancy and refusal at the general population level. There is less research on how misinformation and
disinformation on social media affects COVID-19 perceptions by different ethnic groups, particularly Hispanics.
This group has been the most affected by COVID-19 in the US, and includes a community where health
disparities and inequitable gaps in social determinants of health prevail. Since Hispanics rely more on social
media to obtain information on COVID-19 than any other ethnic group, it is imperative to expand research on
mitigating the effect of misinformation and disinformation through these communication channels.The general
objective of this proposal is to expand on earlier studies completed by the PI and co-investigators on appropriate,
culturally sensitive, strategies to disseminate accurate information on COVID-19 prevention and treatments. We
will pursue the overall objective through these specific aims: (1) develop a social network analysis model to
estimate degree of COVID-19 misinformation and disinformation consumed by the Hispanic community; (2)
conduct focus group sessions with representative Hispanic community members; and (3) complete an economic
impact analysis of proposed informational strategies for Hispanics. The study will take place in El Paso, Texas,
and introduces several key innovations. First, development of a social network model to evaluate social media
data in both English and Spanish, and considering social media platforms in the US and Mexico. We believe that
Mexican social media traffic influences Hispanic populations in the US. Second, development of a longitudinal
misinformation/disinformation index, which will allow estimating degrees of misinformation and disinformation
impact over time and between ethnic groups. Third, implement a combination of focus groups across different
Hispanic demographic groups which will: a) complement findings from the social network analysis model; b)
obtain in-depth data on relevant social media channels; c) estimate changes on risk perception of COVID-19
emergencies; d) define risk attitudes post-vaccine; e) provide a scale on the degree of COVID-19 infection and
prevention literacy; and f) forecast potential health attitude and behavior changes. Specific interest will be on
including sessions targeting Hispanic women, elderly, and persons with chronic diseases, disabilities, and
substance use disorders. Lastly, an economic impact analysis will provide program evaluation estimates based on
potential intervention healthcare cost savings, and quality of life changes. This proposal provides innovative
quantitative approaches to measure the effect of COVID-19 misinformation and disinformation among Hispanics,
and to help define appropriate, culturally sensitive, strategies to eliminate health disparities in this community. Our
research team includes bilingual and bi-cultural specialists with profound knowledge of the Hispanic population in
El Paso, and other similar communities in the country. This expertise will allow us to propose research models
transferable to different regions and groups in the US, and other countries.

Public health relevance
PROJECT NARRATIVE Many studies have shown the effect of social media misinformation and disinformation on COVID-19 vaccination hesitancy and refusal. However, there is little research on how to mitigate the spread of COVID-19 misinformation and disinformation, particularly among Hispanics. The goal of this project is to provide hard evidence to support effective, culturally sensitive, interventions to disseminate accurate information on COVID-19 prevention and treatments to the Hispanic population, particularly for groups severely affected by this pandemic such as the elderly and chronically ill Spanish speakers.